Stroger Hospital of Cook County (SHCC) NCORP

John H. Stroger Jr, Hospital of Cook County (SHCC) in Chicago, Illinois is the major tertiary
care site for the Cook County Health and Hospital System. The majority of cancer cases
are from urban populations and are predominantly African American. The
SHCC NCORP plans to continue to strengthen and improve coordinated care and
clinical research for patients through participation in NCTN programs. The
SHCC NCORP will continue to foster relationships with current cancer research bases
to facilitate broad and improved participation in cancer control, prevention, and care
delivery research for breast, lung, prostate, gastrointestinal, brain, hematologic, head and
neck, and gynecologic cancers; facilitate transfer of state-of-the-art quality oncology care
and new technology to patients in their own communities, through participation in NCI-approved clinical trials; focus on prevention, control and survivorship as methods for reducing cancer incidence, morbidity and mortality; encourage multidisciplinary cancer care and integrated research at the local level; participate in cancer care delivery research which accrue to trials relevant to process improvement and implementation activities by coordinating the existing infrastructural
features of the Cook County Health & Hospitals System and CountyCare’s Managed Care
Community Network; continue to be a source of annotated tissue and blood samples for
translational research projects such as the Early Onset Malignancy Initiative and the
Patient Derived Xenograft project; continue scientific activity at the research base level by
chairing an ECOG group-wide cancer control study concerning reproductive issues of
female cancer patients that were conceived, designed, and initiated by the SHCC
NCORP; and increase participation in symptom science research.

Public health relevance
Conduct of NCIs National Clinical Trials led to substantial improvement in overall survival in the United States for patients with oncological disease. The objective of this project is to participate in NCI sponsored clinical trials focused on cancer care delivery research, treatment, prevention, cancer control and survivorship as methods for reducing cancer incidence, morbidity, and mortality. In this project, we will develop, strengthen, and improve coordinated patient care and clinical research in local communities.